Task Order 2: The Interventional Agent Development Services Program

This contract provides for lead identification, development, chemistry and synthesis services under the NIAID Preclinical Services for the Development of Interventional Agents Program.